Optimizing Developmental Outcomes in Early Childhood After Neonatal Opioid Withdrawal Syndrome

PROJECT SUMMARY / ABSTRACT. Neonatal opioid withdrawal syndrome (NOWS) is a major public health
problem. While existing findings suggest an increased biological risk of neurodevelopmental impairment, the
direct developmental effects are nearly impossible to disentangle fromsocioeconomic, environmental, and family
factors. Children with NOWS are often exposed to multiple adverse childhood experiences (ACEs) with known
detrimental effects on long-term health, however, positive childhood experiences (PCEs) can buffer the effects
of ACEs, promoting positive adaptation. In this proposal our objective is to identify PCEs associated with optimal
developmental outcomes as meaningful and feasible future intervention targets. To achieve this goal, we
propose incorporating lived experience through an active partnership with a local community advisory board and
an innovative, strengths-based focus on positive experiences. We will capitalize on our established, prospective
longitudinal cohort of children with a history of NOWS, adding a school-age assessment to establish a more
complete developmental trajectory with a comprehensive evaluation of socioeconomic, parental, and
environmental variables. We will accomplish this study through the following specific aims: (1) Engage key
community members as active partners in the research process to participate in identification of key patient-
centered outcomes and explore acceptability, appropriateness, and feasibility of potential interventions, (2)
Assess the independent and moderating effects of total PCEs/ACEs and longitudinal measures of parenting on
school-age neurodevelopmental outcomes in a prospective cohort of infants with NOWS, (3) Examine the
association between the individual PCEs and components with neurodevelopmental outcomes in children with
a history of NOWS. We use several novel concepts that differentiate this proposal and line of research from
others including an analysis plan directed by positive psychology principles and incorporation of key
community members in all phases of the project to improve study processes, reduce barriers, and facilitate
meaningful results. I will work with a team of experienced mentors (Drs. Freisthler, Taylor, Sege, Breitenstein &
Rausch) to increase my competency in three critical areas: (1) community-engaged research, (2) design and
analysis of longitudinal studies, (3) methods for assessment of and intervention to promote PCEs and
prevent ACEs. These three training objectives will be accomplished through formal coursework, interactive
workshops, presentations and conference attendance, completion of my research aims, and hands-on
mentorship activities with my diverse, multi-disciplinary group of mentors and collaborators. This early career
development award will provide the necessary candidate training and foundation for an R01 testing the efficacy
of an intervention to increase relevant PCEs identified during the K23, propelling an independent, federally
funded program of research designed to promote optimal developmental outcomes in children with in-utero
substance exposure.

Public health relevance
PROJECT NARRATIVE We have little knowledge of factors that promote optimal neurodevelopmental outcomes in opioid-exposed infants. In this K23, we propose incorporating lived experience through an active partnership with a local community advisory board with an innovative focus on positive experiences in an established, large prospective longitudinal birth cohort of children with neonatal opioid withdrawal syndrome. Our investigation of children who exhibit positive adaptation in the face of biological and social adversity will identify specific protective or promotive factors for optimal neurodevelopment in this high-risk population which could serve as future intervention targets.